Functional Role of the Enterococcal Polysaccharide Antigen

Enterococci represent one of the leading causes of infections among hospitalized patients and
residents of long-term care facilities. In the USA, there were over 50,000 cases of enterococcal
infections in 2017, with ~10% fatality rate. The majority of infections are caused by
Enterococcus faecalis and E. faecium, which include bacteremia, urinary tract and surgical sites
infections, and endocarditis. E. faecalis and E. faecium display high levels of natural and
acquired antibiotic resistance that severely limits the treatment options. The major component of
streptococcal cell wall is the Enterococcal Polysaccharide Antigen (EPA). The recently solved
structure of EPA consists of a polyrhamnose backbone decorated with a polyribitol phosphate-
containing teichoic acid. While a hypothetical mechanism of EPA biosynthesis has been
proposed, studies are required to test it. The goal of this application is to decipher the critical
steps of EPA polyrhamnose and teichoic acid assembly. In addition, we will examine the role of
EPA in binding to the enterococcal autolysins and the resistance mechanism to host
antimicrobial protein expressed in the intestinal epithelial cells, ReGIIIγ. We will utilize a
combination of genetic, analytical and biochemical methods to answer these questions. The
enzymes of EPA biosynthetic pathway constitute promising targets for the development of novel
antimicrobials to combat enterococcal infections. Thus, the proposed experiments will provide a
better understanding of cell wall biogenesis in enterococci to enable the development of
alternative approaches to treat drug-resistant infections. Furthermore, the proposed studies will
enhance our understanding of the functions of EPA in antimicrobial resistance and persistence
of enterococci in gut microbiota.

Public health relevance
Enterococcus faecalis and Enterococcus faecium are important nosocomial pathogens that cause life-threatening infections. The goal of the proposed studies is to determine the mechanism and the function of the Enterococcal Polysaccharide Antigen to enable the development of alternative approaches to treat these drug-resistant infections.